Optimizing PrEP implementation and effectiveness among women at high risk for HIV acquisition in South Africa

Project Summary/Abstract
The goal of this study is to identify effective approaches and implementation strategies to empower young
women at high risk for HIV in South Africa to utilize and persist on pre-exposure prophylaxis (PrEP) for HIV
prevention during periods of elevated risk for HIV acquisition. PrEP uptake remains low among young women
and use by FSW and AGYW halves by 1 month and continues a sharp decline during the first 3-6 months;
effective strategies to target these critical periods are needed. The proposed study is embedded within TB HIV
Care’s large-scale existing PrEP delivery program for young women across 12 sites in South Africa. The
design leverages routinely collected data combined with strategic collection of de novo data and modifications
to the delivery of existing implementation strategies to inform effective PrEP scale-up. Specific Aim 1:
Measure ongoing PrEP implementation (e.g., acceptability, adoption, fidelity, cost) and identify implementation
strategies associated with PrEP uptake and sustained use. Approach: Assess ongoing program
implementation (e.g. direct observation methods, provider assessments, implementation logs) and conduct an
interrupted time-series analysis using existing, program data (2016-2020) and changes to PrEP adherence
interventions introduced over time (e.g. PrEP peer ambassadors, loyalty rewards program, etc.). These data
will be used to identify effective PrEP interventions within the program and to further refine PrEP
implementation strategies. Specific Aim 2: Evaluate the relative effectiveness of modified PrEP
implementation strategies on increasing uptake and sustained PrEP adherence among marginalized
young women. 2a. Approach: Use a cluster randomized design to evaluate the content and reach of PrEP
social influence campaign, and its effect on PrEP uptake and persistence. 2b. Approach: Conduct a cluster
randomized trial focused on modifying implementation strategies of existing peer support interventions to
improve PrEP persistence, by varying the actor, intensity and duration of the implementation strategy. Relative
effectiveness of implementation strategies at achieving 1, 4 and 7-month adherence will be compared and
measured through programmatic PrEP refill data. Specific Aim 3: Identify a set of preferred PrEP
implementation strategies for young women based on the projected population-level HIV prevention
transmission modeling and cost-effectiveness analyses. Approach: We will extend, re-parameterize, and
analyze our previously validated deterministic mathematical model of heterosexual HIV transmission in
Southern Africa, which captures direct and indirect (spillover) prevention benefits of PrEP in the population of
interest (AGYW and FSW) and the wider population. This will quantify the population benefits (infections
inverted) of the PrEP implementation strategies and will include a full economic evaluation.

Public health relevance
Project Narrative This implementation science study utilizes the multiphase optimization strategy (the MOST framework) to comprehensively optimize and evalulate implementation strategies to improve PrEP adherence among young women (≤24 years) at high risk for HIV acquisition in South Africa. The design (1) leverages existing programmatic data and interventions along with the strategic collection of de novo data to inform implementation adjustments intended to promote PrEP uptake, adherence and persistence, then (2) optimizes the existing interventions through modifications of actor/intensity/duration, evaluating the overall effectiveness of these approaches in two short-duration cluster randomized trials embedded within the existing program infrastructure. Finally, population effectiveness and cost-effectiveness of the implementation strategies will be estimated through tranmission modeling to inform PrEP scale-up for women in South Africa.